Admin-Core-001

ABSTRACT – Administrative Core
This proposed Program’s overarching scientific goal is to understand the immune determinants of pediatric HIV
reservoir establishment and maintenance. To ensure successful completion of the scientific Aims, the
Administrative Core will coordinate oversight of all Program activities, create regulatory and NIH compliance
documentation, and manage data and communication. The Core will serve as the Program hub for ensuring
adherence to biorepository and institutional animal use policies and for coordinating the transfer of specimens
and data. The Core will drive the Program’s focus on regular, consistent communication and will coordinate
meetings to ensure extensive integration across Projects and Cores and to solicit feedback from the external
Advisory Committee. The Administrative Core will also play a key role in ensuring the mentoring of early-stage
investigators (ESIs) in Project Leadership roles, with support from the overall Program PI, Project Co-Leads,
and the Emory Center for AIDS Research (CFAR). The Administrative Core will ensure fiscal accountability
and proactively identify areas in which funds may need to be reallocated. This will be a key service of the
Administrative Core that will help determine study directions in the later years of the project period. This
function will be complemented by purposeful engagement of additional funding opportunities and strategic
planning for future studies based on the results of the Program. The Administrative Core will also serve as the
main contact for financial and data management with the Emory CFAR Cores that will be leveraged in this
Program. Finally, the Core will contribute to Program synergy through the use of collaborative, cloud-based
software that ensures the results generated across Projects are efficiently communicated and can be easily
tracked and updated through the utilization of cloud-based computing outlined in the Bioinformatics Core.
Regular maintenance of shared documents, experimental progress, and milestone achievement will allow for
timely communication with the scientific community including the production of abstracts and manuscripts. The
communication services provided by the Administrative Core will be critical in ensuring the objectives of each
Research Project are met and that findings are disseminated to a broad public. By harnessing Emory’s existing
research support environment and history of collaboration, this Core will ensure rapid Program start-up,
including structure, efficiency, and expertise to support the proposed work.